Ph.D. Training in Neuroscience

Modified Project Summary/Abstract Section
We propose to continue a Jointly Sponsored Predoctoral Training Program in Neurosciences that
is the major source of support for early year students in the Ph.D. Program in Neurosciences at
Harvard University. The goals of this interdepartmental Ph.D. program, established in 1982, are
(1) to organize the neuroscientists at Harvard Medical School, its affiliated hospitals, and Harvard
College into a single training faculty cohort; and (2) to train research scientists and teachers who
are interested in mental health, diseases of the nervous system, and fundamental mechanisms of
the brain. The training program is designed to provide talented trainees with a broad and
thorough background in neuroscience; to train them in quantitative and statistical methods in
experimental design and analysis; and to mentor them in performing original and rigorous
research in important areas of neuroscience. During the first year, students are provided with
initial preparation in quantitative approaches to scientific endeavors. This is followed by a yearlong
course, The Discipline of Neuroscience, which provides integrated and rigorous training in
concepts central to our understanding of the development, function, and diseases of the nervous
system at the levels of cellular signaling, circuit computations, and behavior generation. All
students take an additional course in quantitative/statistical approaches to Neuroscience, as well
as a neuroanatomy course and two electives. Students also rotate through three different
laboratories during the first year. Following the coursework, laboratory rotations, and a
preliminary examination, students begin full time, mentored dissertation research. During the
program, students are also involved in other ongoing training activities including journal clubs,
seminars, retreats, skill workshops, and data presentation. There are currently 148 graduate
students enrolled in the Program in Neuroscience; we are requesting support for 14 students,
divided between the first and second year of graduate education. There are 183 faculty in the
Program in Neuroscience; the 82 faculty who are currently most actively involved in graduate
education are training mentors on this proposal. Considerable effort has gone into making this
program a highly interactive group with extensive formal and informal contacts between students
and faculty.

Public health relevance
Project Narrative The goals of this interdepartmental Ph.D. program are (1) to organize neuroscientists at Harvard Medical School, its affiliated hospitals, and Harvard College into a single training faculty cohort; and (2) to train research scientists and teachers who are interested in mental health, diseases of the nervous system, and fundamental mechanisms of the brain.